Modulation of PDE4B by Aptamers for the Treatment of Alcohol Use Disorder

Project Summary
Alcohol use disorder (AUD) affects over 14 million Americans, causing significant physical, emotional, and
social harm, and contributing to over 178,000 deaths annually. Current medical treatments for AUD, such as
naltrexone, acamprosate, and disulfiram, demonstrate limited efficacy. Recent genome-wide association
studies (GWAS) have identified phosphodiesterase 4B (PDE4B) as a significant genetic risk factor for alcohol
consumption and AUD. This suggests that PDE4B plays a crucial role in the predisposition to substance abuse
by regulating cAMP levels in brain regions involved in reward processing and addictive behaviors. Our
company, EnvisBio LLC, aims to develop novel therapeutic agents targeting PDE4B to treat AUD. Specifically,
we propose to identify aptamers that regulate PDE4B activity. Aptamers are single-stranded oligonucleotides
that fold into defined conformations to bind their targets. They offer several advantages over traditional small
molecule inhibitors and large biomolecules, including ease of chemical synthesis, lack of immune response,
and the potential for modification to enhance stability and blood-brain barrier penetration. We propose two
Specific Aims in this Phase I SBIR. Aim 1 involves multiple parallel approaches to screen and identify
aptamers that bind to PDE4B in humans and rats. In Aim 2, we will test the function of aptamers in cell-based
assays. By achieving these aims, we will identify PDE4B-specific aptamers with high specificity that are
negative allosteric modulators. A subsequent Phase 2 SBIR project will allow us to test the in vivo effect of
these modulators in rat models of alcohol self-administration, with the ultimate goal of advancing them into
human clinical trials for treating AUD.

Public health relevance
Project Narratives Alcohol use disorder (AUD) significantly impacts millions of Americans, with current treatments showing limited success. Leveraging recent genetic insights, EnvisBio LLC aims to develop novel therapeutic agents by identifying aptamers that target phosphodiesterase 4B (PDE4B), a key enzyme implicated in AUD. This Phase I SBIR project focuses on developing and testing these aptamers, paving the way for future in vivo studies and potential human clinical trials.